Project 2: Targeting RTK Co-Dependencies in Triple-Negative Breast Cancer

PROJECT SUMMARY
Despite extensive efforts to characterize the genomes and proteomes of triple-negative breast cancer
(TNBC), no dominantly-acting mutated RTK has emerged as therapeutic target in TNBC. Instead, TNBCs exhibit
broad, rather than selective, hyper-activation of RTK signaling, with several proto-oncogenic RTKs hyper-active
in the same tumor. Recent discoveries have revealed that the coordinate activation of RTKs observed in TNBC
is a result of inactivation of the protein tyrosine phosphatase PTPN12. In the current proposal, we aim to translate
our new knowledge of how RTKs are aberrantly activated and drive TNBC progression into a new therapeutic
approach for TNBC patients.
Data from our team and confirmed by others indicates that PTPN12 functions as a tumor suppressor by
restraining the activity of a select set of proto-oncogenic RTKs, including MET and PDGFR?, binding these
receptors and suppressing downstream signaling. PTPN12 is compromised in 45-55% of TNBCs, and we have
shown in in vitro and pre-clinical models of TNBC that inactivation of PTPN12 leads to hyper-activation of MET,
PDGFR?, and a small subset of other RTKs. Importantly, this provokes the therapeutic hypothesis that
PTPN12-deficient TNBCs can be treated by combined targeting of RTKs like MET, PDGFR, and potentially
other RTKs that are locked in the chronically active state. To translate these pre-clinical findings into a new
therapeutic approach, we will evaluate the efficacy of the well-tolerated MET/PDGFR inhibitor sitravatinib as
monotherapy in metastatic TNBC patients, develop rational strategies to combine sitravitinib with standard of
care therapies, and explore new ways to capitalize on the anti-tumoral and pro-immune effects of sitravatinib in
the context of immune checkpoint therapies.
Herein, our mechanistic, pre-clinical, and clinical studies will evaluate the proof-of-concept for the use of
sitravatinib to treat PTPN12-deficient TNBC and lay the groundwork for the next generation of combination
approaches for TNBC and other RTK-dependent cancers.

Public health relevance
PROJECT NARRATIVE Our proposal aims to develop new strategies to combat a common and aggressive subtype of human breast cancer (triple-negative breast cancer, or TNBC). We recently discovered a new mechanism that contributes to the coordinate hyperactivation of RTKs in TNBC and invokes a new therapeutic entry point through which to target these cancers. We propose to translate these preclinical findings into a new therapeutic approach by evaluating the efficacy of the well-tolerated RTK inhibitor sitravatinib as monotherapy in metastatic TNBC patients, assessing sitravatinib in combination with standard of care taxane chemotherapy, and capitalizing on the pro-immune effects of sitravatinib in combination with immune checkpoint therapies.